Molecular correlates of sub-regional thalamic degeneration in multiple sclerosis

ABSTRACT
Multiple sclerosis (MS) is an immune-mediated disease of the human central nervous system (CNS)
that involves demyelination and degeneration of both white matter and gray matter. Deep grey-matter
structures such as the thalamus have received significant attention in MS research due to their early
volume loss. The thalamus is far more than just a “relay station”; organizing afferent and efferent
information processing, its connectivity to multiple regions implicates it in fatigue as well as motor,
cognitive, and sensory impairments in individuals with MS. Thalamic atrophy is a predictor of disability
and cognitive impairment in all disease courses of MS, as well as a predictor for conversion of clinically-
isolated syndrome into MS. While thalamic atrophy is established in MS, the exact mechanisms
underlying thalamic degeneration are not well-characterized. We have assembled a strong team of
investigators with interdisciplinary and complementary expertise in order to identify the molecular
correlates of the thalamic degeneration in MS. Recent data support the hypothesis that demyelination
outside the thalamus, affecting the functional and anatomic connections, may drive selective
neurodegeneration within the thalamus. Preliminary results have identified three thalamic regions: lateral
geniculate nucleus (LGN), pulvinar (PV) nucleus, and centro-medial (CM) nucleus as a) having
preferential volume loss, and b) significantly correlating with greater neurological disability in patients
with progressive MS. We therefore hypothesize that preferential volume loss of certain thalamic sub-
regions may be due selective vulnerability of their neuronal/glial populations. Using postmortem MRI,
we identified cohorts of postmortem MS brains with mild or severe volume loss and minimal
demyelination in the thalamus. In addition, we also include a recently-identified novel group of MS
patients (termed myelocortical MS) without any white-matter lesions, but comparable thalamic atrophy.
The main goal of this exploratory proposal is therefore to generate, identify, and validate a molecular
pattern representative of thalamic volume loss in MS using single-cell RNA sequencing (sc-RNA seq).
The proposed study will use well-characterized samples for Aim 1a) sc-RNA seq; Aim 1b) spatial
transcriptomic assays; and Aim 1c) validation of novel cell clusters to investigate the molecular
alterations underlying thalamic atrophy in MS. These studies will reveal the genetic signatures
associated with thalamic regions that are vulnerable and contribute to volume loss in MS patients.
Successful completion of the current study will provide a significant step forward towards future research
in monitoring and eventually preventing thalamic atrophy and neurodegeneration in MS patients.

Public health relevance
Project Narrative Multiple sclerosis (MS) is the most common inflammatory demyelinating disease of the central nervous system. Neurodegeneration is the major reason to drive the continuous neurological decline and studies have shown that the brain region known as `thalamus' is a predictor of neuronal loss in MS. Unfortunately, the mechanisms underlying neurodegeneration are not known, and therefore this proposal aims to investigate the cellular and genetic changes that correlate with neurodegeneration in MS thalamus.